Metabolic Reprogramming in Experimental Deep Vein Thrombosis and Resolution

Project summary
Venous thromboembolism (VTE), encompassing deep vein thrombosis (DVT) and its major short-term
complication, pulmonary embolism (PE), represents a significant health issue in the US and worldwide. The
mainstay of current DVT treatment is oral anticoagulant therapy. It decreases the risk of DVT reoccurrence but,
unfortunately, does not mitigate inflammation or facilitate venous thrombus (VT) resolution, which correlates
with postthrombotic syndrome (PTS) in humans. Even pharmaco-mechanical thrombectomy allows the
removal of only limited amounts of thrombus and has minimal efficacy in preventing PTS. Therefore, significant
therapeutic gaps exist in providing safer and more effective treatments for DVT and PTS. Given the
thromboinflammatory nature of DVT, the major problem is that resolving or residual venous thrombus, even
after partial removal via systemic or catheter-directed thrombolysis or stenting, confers local inflammation,
leading to persistent fibrotic venous wall injury resulting in PTS. We propose to address this problem by testing
the innovative concept that manipulating metabolic reprogramming by targeting dimeric pyruvate kinase M2
(PKM2) in platelets and neutrophils will inhibit acute venous thrombus formation and, at later stages, targeting
PKM2 in macrophages will enhance efferocytosis, thereby limiting fibrotic venous wall injury and accelerating
VT resolution. The concept builds upon our exciting findings that limiting PKM2 dimerization inhibits platelet
activation, reprograms pro-inflammatory into anti-inflammatory macrophages, and enhances the macrophages’
efferocytotic activity—the ability to clear apoptotic cells that are known to exacerbate inflammation—and
inhibits collagen synthesis in vein fibroblasts. Using human samples and cell-specific mutant mice, we propose
further defining whether metabolic reprogramming by targeting dimeric PKM2 limits chronic inflammation and
accelerates VT resolution. In Aim 1, we will define the regulatory role of PKM2 in acute DVT progression. In
Aim 2, we will determine whether targeting PKM2 at later stages will limit local inflammation, accelerate VT
resolution, and prevent PTS. A strength of the proposal is that we propose to test novel strategies to improve
vascular integrity and motor function in the DVT-affected limb using the femoral vein thrombosis model in mice
and rats. Our team has extensive collaborative expertise, which will increase the feasibility and the likelihood of
success. The overall impact of the proposed research is high because the knowledge gained from this
proposal will significantly move the field of DVT by defining novel mechanisms contributing to common
pathways from acute to chronic inflammation and leading to fibrotic damage of the venous wall.

Public health relevance
Project Narrative Metabolic pathways are increasingly recognized as potential targets for therapeutic interventions in multiple diseases. Platelets and leukocytes play a critical role in the pathogenesis of deep vein thrombosis and fibrotic venous wall injury, resulting in postthrombotic syndrome, which remains a serious healthcare burden. This proposal will explore the potential of manipulating metabolic reprogramming as an innovative approach to targeting thromboinflammation in venous thrombosis and accelerating thrombus resolution.